UC Berkeley-UCSF Health Services Research Training Program

Project Summary
During this time of rapid evolution and uncertain future in the US healthcare system, it is critical that the US
prepare a new generation of scientific leaders with the interdisciplinary training, flexible critical thinking skills
and real-world grounding to provide the necessary leadership to make sound decisions for our future. The
University of California, Berkeley (UC Berkeley) and University of California, San Francisco (UCSF), widely
regarded as two of the top public universities in the world, both have long-standing health services research
(HSR) training programs. UC Berkeley and UCSF propose a five-year renewal of the joint HSR T32 training
program for four predoctoral and two postdoctoral trainees. The overall objective of the fellowship program is
to harness collaboration, complementary skills, and training capacity of the two institutions to provide an
outstanding training experience that emphasizes the application of interdisciplinary advances in social,
behavioral, and data sciences to real world challenges of clinicians, healthcare delivery systems, and health
policy makers. The predoctoral program provides rigorous training in research methods central to HSR,
including data science, quasi-experimental methods, econometrics, and implementation science, as well as
opportunities to partner with health care organizations and systems to conduct research that is responsive to
their priorities. Predoctoral trainees are required to have previously completed coursework in epidemiology,
economics, and statistics, and during our program they complete courses in research design, advanced
statistics, health economics, public policy, and organization behavior. The four predoctoral traineeships are
selected on an annual basis and each can be reappointed for an additional year, depending on coursework
and research performance. The postdoctoral program, administered by the UCSF Philip R. Lee Institute for
Health Policy Studies, is a two-year fellowship program that provides intensive experiential HSR training to
doctorally-trained social and behavioral scientists, as well as doctoral-level health professionals with the
equivalent of an MPH degree. Throughout their training, trainees participate in biweekly colloquia at UCSF
and UC Berkeley to expose them to cutting edge research in progress by nationally and internationally
recognized health services researchers.

Public health relevance
Project Narrative Training a new generation of scientific leaders in health services research (HSR) is crucial for improving the quality, efficiency, and equity of health care delivery in the United States. The UC Berkeley-UCSF Health Services Research T32 uses an interdisciplinary social and behavioral science approach to health services research training at both pre- and postdoctoral levels. The faculty group’s application of interdisciplinary advances -- including in data science, behavioral economics, and implementation science methods – to issues of direct relevance to policymakers and health care organization leaders, and close mentorship, equips trainees to conduct partnered health services research that can generate evidence to improve access to care, affordability, quality, patient outcomes, and to advance equity.